DNA transduction in intestinal microbiomes and the spread of pathogenicity traits

Project Summary
Horizontal gene transfer (HGT) is a driver of rapid evolution and adaptation in microbial communities. HGT
spreads genes among and between bacterial species and is relevant to human health as this process
disseminates antibiotic resistance genes, genes involved in toxin production, and other virulence traits.
Transduction, the transfer of genetic material by bacterial viruses (phages) or virus-like particles (VLPs), is
widespread among bacteria and plays an essential role in the evolution of bacterial pathogens. Despite the
importance of transduction to human health, our understanding of the taxonomic range, frequency, and
mechanisms of transduction between commensal and pathogenic bacteria are limited. Currently, the study of
transduction in microbial communities relies on the reconstruction of historical transduction events that shaped
extant microbial genomes. These reconstructions do not measure ongoing transduction. To address this
challenge, we developed a novel method termed transductomics, which allows us to measure near to “real time”
transduction in microbial communities and identifies the DNA sequence transduced to new bacterial recipients.
Transductomics uses shotgun metagenomic DNA sequencing to identify and characterize DNA originating from
microbial cells that is carried in phages or VLPs. This technique has the power to identify transducing viruses
within microbiomes and can be used to determine the spread of virulence and antibiotic resistance traits that
contribute to pathogen success. Recent work, including our own, has shown that phages and VLPs are abundant
in the intestine. This indicates that phages and/or VLPs capable of transducing DNA to and from bacteria are
significant are understudied players in the spread of genetics traits that can promote bacterial pathogenesis.
Although our transductomics method readily identifies both active and potential transduction occurring within
diverse bacterial communities, it lacks automation, is low throughput, and labor intensive. The main goals of this
project are to establish high-throughput methods with refined resolution that allow for the measurement and
identification of transduction within bacterial pathogens and microbiomes and to examine how transduction
spreads virulence traits within the microbiota. Identifying transducing events within the microbiota and among
established pathogens will facilitate the development of precision therapies aimed at curtailing the spread of
virulence and antibiotic resistance genes among bacteria, which can limit pathogenesis.

Public health relevance
Project Narrative Bacteria rapidly evolve new capabilities, such as virulence, by acquiring genes from other bacteria through a process called horizontal gene transfer (HGT). HGT occurs by different routes, one of which is the transfer of DNA carried by bacteria infecting viruses (phages) or virus-like agents, known as transduction. This project uses innovations in next-generation DNA sequencing, metagenomics, and metaproteomics to uncover the identity and magnitude of transduced DNA in the microbiota and intestinal pathogens, and is a first step in understanding how transduction of bacteria influences human health.